Indiana Clinical and Translational Sciences Institute

The Indiana Clinical and Translational Sciences Institute (Indiana CTSI) was created in 2008 as a statewide partnership to accelerate clinical and translational research by the three research universities, Indiana, Purdue and Notre Dame, with partner health care systems and providers, community and patient stakeholders, local foundations, corporate and government partners. The mission of the Indiana CTSI is to bring together Indiana’s brightest minds to solve the most pressing health challenges by serving as the statewide catalyst for clinical and translational research and improve human health across Indiana, the nation and beyond. The Indiana CTSI fosters a collaborative research environment, provides resources and services to conduct the highest-quality clinical and translational research, offers education and training programs to build a robust translational workforce, engages our community as a partner at all levels, identifies and removes barriers to research through translational science approaches, and functions as an exemplary member of the national CTSA network. The CTSI plans to accomplish its mission through five Specific Aims: Aim 1. Accelerate training and research opportunities across the state to create a trusted translational research workforce that demonstrates respect, responsibility, and trustworthiness through effective communication, team science and authentic stakeholder engagement. Aim 2. Enrich and integrate our network of patient, health care, corporate, community, and government agency partners to better engage and empower all populations across Indiana, focusing on regions and groups with poorest health outcomes. Aim 3. Enhance access to I-CTSI programs and services to facilitate and expedite impactful clinical and translational research that is innovative, collaborative, and ethical, and effectively disseminates and implements evidence-based interventions across the state. Aim 4. Identify barriers, create solutions, and disseminate novel approaches for best practices of clinical and translational science through community and stakeholder engagement, pilot funding, and a trustworthy and integrated translational research ecosystem. Aim 5. Leverage our statewide informatics platform and innovative analytic capabilities to harmonize disparate data sources in collaboration with health systems across the state and with deliberate inclusion from rural and urban populations to advance health for all. In 2030, at the end of this seven-year renewal funding period, we envision the I-CTSI will transform our statewide research ecosystem with deliberate attention to a statewide approach in our partnerships, workforce development and research engagement. We will accelerate innovation and rapidly implement evidence into practice in order to make Indiana a healthy state for all.

Public health relevance
The Indiana Clinical Translational Science Institute is a partnership among Indiana's three research-intensive universities, Indiana University, Purdue University, and the University of Notre Dame, and the Regenstrief Institute, and has a distinguished history of documented success and robust statewide research, educational, and community infrastructure on which to build its expansion in this new CTSA funding period. We will transform our statewide research ecosystem with deliberate attention to the principles of trustworthiness and community engagement in our partnerships, workforce development and research engagement. We will accelerate innovation and rapidly implement evidence into practice in order to improve health in Indiana and beyond.